Statistical Methods for Accurate Estimation and Prediction in Alzheimer's Disease

Project Summary
Longitudinal cohort studies are a rich resource for estimation and modeling of Alzheimer's disease (AD)
progression. Datasets extracted from these studies often feature complex truncation (selection) and
censoring. Estimates based on these datasets are used for (1) clinical trial design; (2) improved understanding
of AD progression, risk and prevention; and (3) individual prediction, but do not fully account for the complex
truncation. This proposal develops methods that make proper adjustments and thereby enhance each of these
essential needs in AD.
Use of time-to-event endpoints in clinical trials for AD is supported by regulatory authorities when the time
origin and the event are clinically meaningful, e.g., onset of cognitive decline and mild cognitive impairment
(MCI). Time-to-event estimation and modeling are needed to support trial design (e.g., numbers of events and
participants, length of follow-up, eligibility). These estimates are commonly based on subcohorts from large
longitudinal cohort studies, which feature complex truncation and censoring. Current estimates use a time
origin of convenience, such as study entry, rather than a clinically meaningful time origin, as required by clinical
trials. Aim 1 develops methods for estimation and regression that enable use of clinically relevant time origins
through proper adjustment for fully and partially sequential truncation in longitudinal cohort studies.
Unbiased estimates of associations between measures of interest in studies of AD such as blood biomarker
levels or amyloid imaging levels and factors such as maternal age at dementia onset or other biomarker values
are important for the evolving understanding of AD progression, which informs drug development and
treatment and personalized risk assessment. Many published regression analyses ignore the censoring and
“cure” (i.e., unobserved latent classes) of these factors and obtain biased associations. Aim 2 develops
methods that adjust for covariates that are subject to censoring or cure and yields accurate estimates of
association.
Accurate predictions of clinically meaningful times-to-event that adjust for subject-specific features are
essential to provide prognostic guidance to patients. Conformal prediction provides a flexible framework for
quantifying uncertainty based on the use of arbitrary prediction algorithms. Conformal prediction targets the
actual event time itself, which is the most meaningful measure for patients. However, it has not been
developed for settings of truncation (Aim 1) or incompletely observed covariates (Aim 2). Aim 3 fills these gaps
and will enable use of conformal prediction in the setting of times-to-events that are clinically meaningful in AD
progression based on longitudinal cohort studies.

Public health relevance
Project Narrative Alzheimer's disease (AD) is in dire need of effective treatments. This intransigent major public health problem is being addressed with urgency, through both clinical trials and observational studies. This proposal address many of the opportunities for improved efficiency and accuracy in the design and analysis of AD studies, which often require thousands of participants and feature truncation (biased sampling) and censoring (incomplete observations).